Enhancing Diversity, Equity, and Inclusion in Mental Health Research: American Psychopathological Association Annual Meetings

From both NIMH and NIDA, we are requesting R13 funds to support attendance of early-career and underrepre-
sented scientists at the 2024, 2025, and 2026 annual conferences of the American Psychopathological Associ-
ation (APPA); exclusively from NIDA, we also request support to help cover meeting costs. Since its founding in
1910, the APPA has sought to promote (1) investigation of disorders of mind and behavior, including their bio-
logical and psychosocial substrates, and (2) mentoring of junior scientists. This R13’s specific aims entail a
significant expansion of our efforts to increase diversity and inclusion in the mental health workforce of scientists
underrepresented in psychopathology research. The themes of our annual meetings are closely aligned with the
aims of the R13. In the 2024-2025 conferences, we focus on population-wide diversity and inequity in mental
health and addiction, addressing variability in prevalence, symptom expression and severity, coping and resili-
ence, illness models, and measurement factors (diversity); we will also address preventable and unjust social
practices toward oppressed groups that lead to worse mental health outcomes, greater burden of disease, and
poorer availability and quality of care (inequities). We intend to generate new mental health research goals via
state-of-the-art discussion of timely topics and methods in multi-level mechanisms of diversity and inequity
(2024) and in prevention/treatment interventions and strategies (2025). The 2026 conference will address the
fruits of the “affect revolution” on how we understand and intervene in psychopathology: it will focus on emotion
regulation/ dysregulation as a cross-cutting process underlying multiple forms of psychopathology and highlight
the role of context in the experience and regulation of emotions. Because key factors enumerated in the 2023-
2024 meetings on diversity and social inequity are contributors to mental illness/addictions and reflect part of
individuals’ context (e.g., marginalization, reduced access to care), the themes of all three APPA meetings will
be linked. The all-plenary format and inclusive environment of the meetings will stimulate vigorous exchanges of
information on concepts, methods, findings, controversies, and gaps in knowledge to identify new research di-
rections, foster collaborations, and – especially for junior scientists and individuals from underrepresented groups
– develop new connections and career opportunities. Activities specifically designed for junior scientists (stu-
dents, fellows, early-career investigators) include a half-day pre-conference workshop, breakfast roundtables
with senior scientists, opportunities for trainees to give oral poster presentations to the entire APPA audience,
and a structured mentorship program of junior attendees led by senior APPA members, including from the Di-
versity, Equity, Inclusion, Accessibility, and Belonging Committee. Funds are requested to cover travel/hotel/reg-
istration costs for junior scientists and investigators from underrepresented groups who would otherwise not be
able to attend APPA and enhance their engagement in the field of psychopathology research. Additional funds
are requested from NIDA to partially cover meeting-related costs related to the aims of the R13.

Public health relevance
PROJECT NARRATIVE Despite substantial investment over several decades, research on the causes and prevention of mental/behav- ioral illness, including substance use disorders, has not led to clinically significant reduction in the disproportion- ate burden of psychopathology on oppressed and marginalized groups including low-income individuals, eth- noracial minoritized communities, and sexual and gender minorities. The 2024, 2025, and 2026 conferences of the American Psychopathological Association (APPA) will address the overarching problem of mental health equity (from etiology to treatment and prevention, plus potential mechanisms). This grant will support APPA’s expanded efforts in promoting the inclusion of early-career and underrepresented scientists in our annual meet- ings and investing in the careers of the next generation of leaders in the mental health and addiction workforces.